RESEARCH SUPPORT SERVICES

The purpose of this contract is to maintain the Institute's capabilities to conduct small studies, program assessments, convene scientific meetings, and have access to the scientific community through presentations and the exchange of scientific information.